Defining the cellular and molecular consequences in TET2 CHIP

PROJECT SUMMARY
This proposal aims to advance our understanding of clonal hemopoiesis of indeterminate potential (CHIP) in
the development of atherosclerotic cardiovascular disease (ASCVD). CHIP is a recently identified acquired risk
factor for ASCVD. With aging, hematopoietic stem cells accumulate mutations that can lead to a proliferative
advantage resulting in CHIP. Tet Methylcytosine Dioxygenase 2 (TET2) is a commonly mutated gene in CHIP
and confers a 50% increased risk for incident coronary disease. How TET2 leads to ASCVD is in humans is
not well understood and there is currently no ability to assess whether a specific TET2 mutation is high-risk.
The central objective of this proposal is to (1) identify TET2 mutations that are high-risk for developing ASCVD
to derive a comprehensive and clinically actionable risk score calculator and (2) identify the aberrant cell states
and signaling pathways among TET2 mutated immune cells in the coronary vasculature. To identify high-risk
TET2 mutations, the candidate will leverage a population-scale human genetics approach in >1 million people
via BioVU and All of Us databases. To identify aberrant cell states and signaling pathways, the candidate will
deploy their novel single cell lineage tracing protocol in coronary vascular tissue followed by validation
experiments via population-based human genetic association studies. The candidate’s career goals are to
become an independently funded physician scientist focused on developing new ways of treating ASCVD. In
addition to the proposed science, the training activities outlined in the candidate’s career development plan are
focused on the crucial skills and experiences necessary to enable an independent research program.
Combined with the direct mentorship of Drs. Alexander Bick and Dan Roden, Vanderbilt University Medical
Center represents an ideal environment for the proposed work and leverage some of the world-class strengths
of the institution. The Bick and Roden labs have deep experience in the methods used in this proposal and are
prepared to support the candidate throughout the entirety of the grant period. Overall, this NHLBI K08 proposal
represents a set of innovative and timely scientific aims combined with a tractable career development plan
that will meaningfully contribute to human health research and catalyze the candidate’s long-term career goal
of developing into an independent investigator.

Public health relevance
PROJECT NARRATIVE This research proposal aims to develop precision therapeutics for the prevention of atherosclerotic cardiovascular disease (ASCVD) associated with Clonal Hematopoiesis of Indeterminate Potential (CHIP). The central hypothesis is that high-risk mutations in TET2, a gene commonly causing CHIP, leads to ASCVD by producing hyperinflammatory phenotypes among resident immune cells in the vasculature. The specific aims of the research are to develop a cardiovascular risk score incorporating TET2 mutations and the pathways through which TET2 mutated cells affect gene expression in coronary vessels.